Molecular Mechanisms of Platelet Alpha Granule Biogenesis

PROJECT SUMMARY
Platelets play central roles in hemostasis and thrombosis. Platelet activation triggers secretion and release of contents
from α-granules, δ-granules and lysosomes that in turn leads to the recruitment and aggregation of additional platelets and
a myriad of physiological responses. While impaired platelet function is associated with disorders that manifest with
moderate to severe bleeding, excessive platelet aggregation is a major cause of morbidity and mortality due to its effect in
cardiovascular disease and stroke. Alpha-granules are crucial to these platelet functions both in health and disease. However,
in spite of the relevance of platelet α-granules for human health, remarkably little is known about their biogenesis. Therefore,
our goal is to understand the pathways and molecular mechanism responsible for the biogenesis of platelet α-granules.
Mutations in VPS33B, VPS16B and NBEAL2 cause the α-granule deficiency and bleeding manifestations observed in
patients suffering Arthrogryposis, Renal Dysfunction and Cholestasis (ARC) syndrome and Gray Platelet syndrome (GPS).
However, the mechanism of action of these proteins in α-granule biogenesis is a mystery. Consequently, a major objective
of this proposal is to address the function of VPS33B, VPS16B and NBEAL2 at the cellular and molecular level.
Platelet α-granules are produced in the megakaryocyte, the platelet precursor cell. In addition to soluble proteins taken
up by endocytosis, α-granules contain hundreds of proteins synthesized by the megakaryocyte. The pathways taken by
megakaryocyte-synthesized proteins to reach the α-granule are unknown. In this proposal, we show that the sorting
endosome is a fundamental precursor organelle in α-granule formation that is used by megakaryocyte-synthesized proteins.
This implies a more complex biogenesis mechanism than previously anticipated. In this application we build on our novel
findings, hypothesizing that fundamental components of the α-granule biogenesis machinery work at the megakaryocyte
sorting endosome by regulating vesicular trafficking. We propose two specific aims. Aim 1 will determine the transport
pathways followed by newly synthesized α-granule soluble and membrane proteins using an innovative method to
synchronize and evaluate transport of proteins to α-granules in real time. We will test the hypothesis that there are multiple,
separate pathways followed by megakaryocyte-synthesized α-granule proteins and test whether α-granules segregate into
distinct populations. Aim 2 will define the molecular mechanism of platelet α-granule biogenesis by: (i) testing the
hypothesis that VPS33B and VPS16B regulate the SNARE-mediated fusion of Golgi-derived vesicles containing α-granule
cargo with sorting endosomes; (ii) addressing the function of novel components of the transport machinery identified here,
including a new complex that coordinates α-granule cargo traffic through sorting endosomes; (iii) testing the hypothesis
that NBEAL2 mediates the exit of α-granule cargo from sorting endosomes in association with actin and Vac14.
This research will transform our view of the platelet α-granule field by bringing about a highly mechanistic
understanding of the biogenesis process. Our work will yield insights into the bleeding and myelofibrosis manifestations
observed in ARC and GPS patients. Ultimately, this knowledge will help design new strategies for the treatment of bleeding
and thrombotic disorders and other diseases in which α-granules have emerging roles including angiogenesis and cancer.

Public health relevance
PROJECT NARRATIVE Platelets are anucleate cells that circulate in the blood and play critical roles in bleeding, stroke and cardiovascular disease (the number 1 killer in the US). Platelet function depends on internal compartments known as alpha granules, which are not well understood. Thus, elucidating the formation of platelet alpha granules is necessary to understand platelet function and the development of new therapeutic strategies for disease treatment and prevention.